Characterization of Nrac, a Novel Cardiac and Adipose Enriched Microprotein

PROJECT SUMMARY
Obesity is a widespread health concern impacting millions of individuals and is strongly associated with
increased risk of cardiovascular disease (CVD). Despite advancements in understanding the metabolic
implications of obesity, the connection between lipid droplet (LD) dynamics and CVD remains relatively
unexplored. This project aims to address this gap by focusing on the functional characterization of a novel
microprotein, Nutritionally regulated adipose and cardiac-enriched gene (Nrac), and its involvement in LD
biogenesis and lipid metabolism within the cardiovascular system. Microproteins, a class of proteins often
overlooked due to their small size, are increasingly recognized for their crucial roles in cellular functions. Nrac,
encoded by the previously annotated noncoding RNA A530016L24Rik, has emerged as a significant player in
lipid metabolism. Prior studies have shown that Nrac is highly expressed in cardiac and adipose tissues, with
dynamic regulation in response to nutritional states. Our preliminary data indicates that a global gene deletion of
Nrac leads to cardiac stress and altered lipid metabolism, emphasizing its potential significance in cardiovascular
health. Furthermore, our data suggests Nrac localizes to the sarcoplasmic reticulum (SR) membrane, the primary
site of intracellular LD biogenesis, and protein interaction data predicts its direct interaction with proteins involved
in this process. Therefore, we hypothesize that Nrac localizes to the SR membrane in cardiomyocytes to
coordinate LD biogenesis and subsequently contribute to lipid metabolism. Through two specific aims,
this research seeks to understand the mechanisms by which Nrac influences LD dynamics and lipid metabolism.
Aim 1 will investigate Nrac's localization and interaction with proteins involved in LD biogenesis using human
induced pluripotent stem cells (hiPSCs) differentiated into cardiomyocytes (hiPSC-CMs). This aim will examine
the endogenous expression dynamics and localization of Nrac, along with functional assays to assess its
potential role in LD biogenesis. Aim 2 will evaluate Nrac's impact on lipid metabolism in a diet-induced obesity
model utilizing Nrac knockout mice. By subjecting these mice to a high-fat diet challenge, this research aims to
determine whether Nrac plays a regulatory role in lipid metabolism, contributing to obesity progression.
Echocardiography, metabolic assessments, lipidomic analyses, and functional studies will be conducted to
evaluate the effects of Nrac deficiency and overexpression on adiposity and cardiac health. Upon completion of
these aims, the project aims to provide a comprehensive understanding of Nrac's role in LD dynamics and lipid
metabolism, particularly in cardiomyocytes. This knowledge could potentially identify Nrac as a therapeutic target
for mitigating lipid abnormalities associated with obesity and reducing the risk of CVD.

Public health relevance
PROJECT NARRATIVE This project aims to investigate the relationship between obesity, cardiovascular disease, and lipid metabolism by investigating the role of the novel microprotein Nrac within the cardiovascular system. The primary focus of this research plan is to elucidate the functional role of Nrac and define its involvement in lipid droplet biogenesis and metabolism within cardiomyocytes. This study is essential for understanding the role of lipid abnormalities in obesity and related cardiovascular disease with the potential to reveal new targets for mitigating these diseases.